Locus coeruleus network architecture of Alzheimer's disease vulnerability

ABSTRACT: The locus coeruleus (LC) is considered to be one of the earliest regions accumulating
hyperphosphorylated tau. The first pretangle deposits occur in young adulthood, and by age 40 the LC is
affected in nearly every case at autopsy. These tau aggregates occur before the earliest cortical involvement in
the entorhinal cortex around age 50, from where they progress to limbic and other cortical regions. The fact
that this highly predictable anatomic pattern of pathology progression occurs along regions that are connected
suggests that LC-brain connectivity is one of the mechanisms contributing to the earliest vulnerability of
accumulation and propagation of tau in Alzheimer's disease (AD). The LC has widespread projections to the
cortex enabling the integration and coordination of communication between segregated regions. However,
even though, tau is omnipresent in the LC of every person above age 40, not everyone will head down to an
irreversible AD path. Thus, to ensure that prevention trials are more effective in these early stages, it will be
critical to distinguish individuals at risk of AD versus those who remain resilient in the face of pathology. To
overcome this barrier, we need to discern LC large-scale network architectural patterns associated with AD
vulnerability versus those conferring resiliency to AD. This will provide a deeper understanding of network
changes related to healthy or pathological aging, improve early detection and contribute to identifying
individuals at-risk for inclusion in prevention trials. The overall goal of this proposal is to characterize and
understand the biological background of LC's specific vulnerability by identifying specific LC- network patterns
contributing to vulnerability to AD versus those that confer resiliency, and map associated genetic traits. We
hypothesize that associating the selective degradation of the LC's capacity to integrate brain networks with AD
pathology will uncover vulnerable and resilient LC-cortical network architectural layouts, which will be
associated with AD-related cognitive decline or resiliency, respectively. To achieve this, we will generate multi-
modal LC tau-vulnerable clusters by utilizing a unique large 7T fMRI adult lifespan brainstem cohort with
novel plasma AD-biomarker data. The architecture of networks emerging from LC clusters will be examined in
this 7T fMRI dataset and in two large-scale NIA-funded, rich multi-modal longitudinal datasets, the Harvard
Aging Brain Study and ADNI. We will examine the following aims: 1) To identify the anatomic vulnerability to
tau along the rostro-caudal axis of the LC and its association with age, sex and APOE; 2) To relate AD
pathology to patterns of LC-cortical network architecture, and identify at-risk versus resilient patterns; 3) To
characterize the genetic brain transcriptome of tau spreading profiles associated with at-risk and resilient LC-
cortical network patterns. The proposed research is innovative and can result in a significant breakthrough for
the field by shifting detection to earlier time points and providing new enrollment strategies or targets for
therapeutic approaches administered earlier in the disease trajectory, when brain damage is not yet irreversible.

Public health relevance
NARRATIVE The locus coeruleus is one of the first sites of abnormal forms of Alzheimer's disease-related tau proteins in the brain, and from there it is assumed to spread through brain connections, altering its ability to coordinate large- scale networks. The proposed study aims to characterize the patterns and genetic features underlying locus coeruleus-related functional networks that facilitate tau spreading and cognitive decline as well as those that provide resiliency in the face of pathology. This project has important public health implications and is relevant to part of the NIH's mission as it will provide insights into the selective vulnerability of the locus coeruleus in Alzheimer's disease and can provide new targets for treatment early in the disease trajectory.